Team Science for MultiScale Data Mining and Functional Validation of Single-Cell Opioid Responses in the Context of HIV

With approximately 296 million people (5.8% of the global population aged 15–64) having used drugs at least
once, the world is facing an unprecedented opioid epidemic. Chronic opioid exposure can lead to long-term brain
function changes and opioid use disorder (OUD). Concurrently, despite advancements in treatment that have
transformed HIV into a manageable chronic disease, evidence shows that opioid use in HIV-infected individuals
can further weaken immune function and exacerbate HIV-related central nervous system (CNS) impairments.
To unravel the intricate interplay between these conditions, several SCORCH data generation and analysis
centers have been funded to generate large-scale molecular profiling data at single-nuclei resolution, allowing
the revelation of cell-type-specific molecular alterations due to chronic opioid exposure and/or HIV infection.
However, the driving forces behind these molecular changes and their underlying regulatory mechanisms remain
elusive, hindering our understanding of these factors and limiting the development of effective therapeutic
strategies.
To address this gap, we propose the DMFV-SCORCH project, an interdisciplinary initiative aimed at uncovering
multi-scale dysregulations resulting from HIV and OUD through population-scale single-nuclei sequencing data,
and validating our findings with advanced genomic assays. Specifically, we aim to identify intra- and inter-cellular
dysregulations that lead to transcriptomic alterations and brain dysfunctions in OUD and HIV. We will address
three key questions: 1) Which cell types are significantly affected, and what epigenetic changes lead to
differentially expressed genes (DEGs) in these cell types? 2) Within a cell, what alterations in the gene regulatory
network (GRN) and 3D chromatin conformation contribute to the DEGs? 3) How do regulatory changes in the
CNS microenvironment, via cell-cell communications (CCC), impact DEGs?
To achieve this goal, we will: 1) develop advanced Artificial Intelligence (AI) methods for data mining on SCORCH
and atlas-level public CNS single-nuclei sequencing data, highlighting multi-scale dysregulations due to
HIV/OUD; and 2) conduct functional validations through advanced genomic assays, such as epigenetic and
transcriptomic manipulations via CRISPR followed by snRNA-seq (e.g., CROP-seq) and high-throughput
screenings using massively parallel reporter assays (MPRA). Collectively, our examination of the
interrelationships among genetic, epigenetic, transcriptional, network, and inter-cellular dysregulations will offer
a robust translational approach to unravel the independent and synergistic mechanisms of OUD and HIV.

Public health relevance
While population-scale SCORCH single-nuclei sequencing data enables the discovery of molecular alterations resulting from chronic opioid exposure and/or HIV infection, the driving forces behind these changes and the underlying regulatory mechanisms remain elusive. Understanding these factors is crucial for developing effective therapeutic strategies. To address this gap, we propose the DMFV-SCORCH project to: 1) develop advanced Artificial Intelligence (AI) methods for data mining on SCORCH and atlas-level public CNS single-nuclei sequencing data, focusing on multi-scale dysregulations due to HIV/OUD, including regulatory alterations driven by epigenetic, transcriptomic, network, and brain microenvironment interactions; and 2) conduct functional validations using advanced genomic assays, such as epigenetic and transcriptomic manipulations via CRISPR followed by snRNA-seq (e.g., CROP-seq) and high-throughput screenings using massively parallel reporter assays (MPRA).